Personalizing Cognitive Processing Therapy with a Case Formulation Approach to Intentionally Target Impairment in Psychosocial Functioning Associated with PTSD

Anticipated Impacts on Veterans Healthcare: Findings have the potential to increase the number of
Veterans who benefit from one of the most effective treatments for posttraumatic stress disorder (PTSD),
Cognitive Processing Therapy (CPT). In addition to reductions in PTSD symptomology, successful completion
of CPT results in improvement in functional impairment, decreases in comorbid symptoms, and enhanced
quality of life. This project tackles an important question for our colleagues within the Office of Mental Health
and Suicide Prevention, who have expressed a need for strategies that enable flexibility while maintaining
fidelity to the demonstrably efficacious CPT protocol. This proposal addresses RR&D’s priority area of
conducting research on cognitive behavioral therapy for Veterans with psychological health conditions.
Project Background: CPT has been widely disseminated throughout VHA with over 4000 VHA providers
certified to provide CPT through the Mental Health Dissemination Initiative to date. However, as CPT has been
implemented several factors have limited its impact on Veterans’ health. Veteran engagement in CPT is
suboptimal, outcomes achieved in Veteran populations are more modest than those obtained with civilians,
and improvements in functioning and quality of life are more modest than those observed in the core
symptoms of PTSD. Strategies for improving patient engagement, enhancing treatment outcomes, and
expanding the success of the intervention to functional impairments are needed for Veterans to fully benefit
from the CPT dissemination initiative. Expanding and enhancing the CPT protocol is a promising strategy for
achieving these goals. Integrating a case formulation (CF) approach into the existing CPT protocol may enable
providers to increase treatment flexibility while maintaining fidelity to effective CPT principles. CF is a
collaborative process between providers and patients that enables providers to tailor cognitive-behavioral
treatments to specific clients’ needs within clear parameters of what justifies deviation from the standard
protocol. Our study team has preliminarily demonstrated that CF-integrated CPT (CF-CPT) yields lower levels
of dropout and a higher proportion of patients losing their PTSD diagnoses than published accounts of CPT.
Project Objectives: Our long-term objective is to build on the success of the CPT Dissemination Initiative on
Veterans’ health by directly targeting functional impairments and enhancing patient outcomes. We propose the
following aims: 1) Compare the relative effectiveness of CF-CPT to CPT in improving Veterans’ psychosocial
functioning quality of life and well-being as well as core PTSD and depression symptoms; 2.) Determine the
effectiveness of CF-CPT as compared to CPT in improving Veterans’ treatment engagement; 3.) Evaluate CF-
CPT’s indirect impact on Veterans’ psychosocial functioning, quality of life, well-being and PTSD/depression as
influenced by improvement in the idiosyncratic clinical challenges targeted by the CF.
Project Methods: We are proposing a randomized control trial in which a national sample of up to 56 CPT-
certified providers will be randomized to administer either CPT or CF-CPT. Each provider will deliver their
assigned version of CPT to four Veterans presenting for treatment in their clinic. Data sources will include pre-
and posttreatment diagnostic interviews, Veteran self-report surveys; administrative data extracted from mental
health progress notes; and therapy process data including daily symptom monitoring diaries (Aim 3. Our
primary Aim 1 outcomes will be standardized measures of functioning, quality of life, and well-being; secondary
Aim 1 outcomes include clinician-assessed PTSD symptomology and comorbid mental health symptoms (e.g.
depression). Data sources for Aim 3 will include standardized measures of the host of clinical challenges that
disrupt therapy and that are specifically targeted by the CF approach as well as novel, idiosyncratic measures
(daily diaries) of challenges.

Public health relevance
Cognitive Processing Therapy (CPT), the evidence-based psychotherapy for PTSD most frequently delivered within VHA, yields large magnitude reductions in primary PTSD outcomes. Corresponding gains in occupational, social, leisure, and sexual functioning, and in health-related concerns, including chronic pain have also been demonstrated. Despite CPT’s effectiveness, there is room for improvement in overall outcomes (about 2/3 retain their PTSD diagnosis) and patient engagement (35-40% drop out prior to treatment completion). Further, improvements in functioning and quality of life are more modest than those observed in PTSD and associated mental health symptoms. Unaddressed difficulties in functioning contribute to premature dropout from EBPs for PTSD among Veterans. Directly targeting impairments associated with psychosocial functioning has the potential to substantially increase the scope of recovery beyond the core symptoms of PTSD and facilitate greater patient engagement, resulting in more Veterans benefitting from CPT.